SCH: Smart Breath- based Diagnosis of Pulmonary Exacerbations in Children with Cystic Fibrosis through Machine Learning: Towards Noninvasive Health Monitoring in Real-Time

Cystic fibrosis (CF) is a genetic disorder that negatively affects young people across the globe. Pulmonary
exacerbations (PEx), episodes of decreased lung function accompanied by coughing, increased sputum
production, and weight loss, are a hallmark of CF lung disease. Besides negative health impacts, PEx
comes with a burden to healthcare costs in the United States and beyond ($10K-$40K USD per episode).
Although PEx can be treated with antibiotics, patients still experience decreased quality of life and
ultimately reduced survival. A point-of-care, rapid, and accurate test to identify impending PEx that would
benefit from treatment could have an impact on families of children with CF and their clinicians through
reducing misdiagnosis and overtreatment. Breath testing, through identifying volatile organic compound
(VOC) biomarkers, holds great promise for the development of home-based/clinical testing solutions for
PEx. The goal of this research is to develop a hand-held smart sensor system that can detect exhaled
VOC biomarkers for PEx noninvasively in real-time. To accomplish this, machine learning will be utilized
to identify a breath-based biosignature of PEx (Aim 1). In parallel, the team will design/test a nanosensor
array to detect the biosignature (Aim 2) and develop a user-friendly smartphone app to be used at-home
or in the clinic (Aim 3). Ultimately, this research will further the development of diagnostic solutions for
PEx, and advance knowledge in a multi-faceted fashion across disciplines including basic science,
chemistry, engineering, medicine, biotechnology, and health informatics. The technological solution is
highly disruptive and challenges the current paradigm of how PEx is diagnosed. From an engineering
perspective, sensors are at the cusp of being translated into biomedical devices, and this research aims to
overcome challenges in selectivity that can also be leveraged for VOC-based diagnosis of other heart and
lung diseases beyond CF. The interdisciplinary team has vast experience in their respective fields, and
their collaboration ensures successful completion of the research. A diverse set of resources/equipment
from the team's laboratories, along with others on campuses, will be leveraged to support research
activities.
RELEVANCE (See instructions):
The research addresses

Public health relevance
public health relevance as it relates to the mission of NHLBI, as cystic fibrosis (CF) is a degenerative lung disease prominent in children that leads to decreased quality of life and reduced life expectancy. The development of a smart sensor system that noninvasively monitors CF-induced pulmonary exacerbations (PEx) in real-time will enable at-home testing solutions, lower healthcare costs, reduce misdiagnosis/overtreatment, and improve clinical outcomes for CF patients.